Role Of The Anterior Hippocampus In The Pathogenesis Of Major Depression

PROJECT SUMMARY: Improving our understanding of the mechanisms underlying the pathophysiology of
major depressive disorder (MDD) is critical for reducing disease burden and improving treatment strategies. The
hippocampus, a critical hub in the limbic system, is implicated in the pathogenesis of cognitive and emotional
symptoms of MDD. The hippocampus differs functionally along its longitudinal axis. The posterior is preferentially
involved with visuospatial navigation and memory, and the anterior with stress processing and mood. Preclinical
studies find that neurogenesis is impaired in the anterior hippocampus in primate and rodent models of
depression and in postmortem studies of unmedicated depressed individuals compared with healthy volunteers
(HV) and medicated MDD. Despite ample evidence implicating the anterior hippocampus in the pathogenesis
and treatment of MDD, hippocampal functioning along the anterior-posterior axis has not been examined in
clinical studies, comparing untreated patients in a major depressive episode (MDE) with HV and remitted MDD
subjects, as well as currently treated versus untreated remitted MDD. This study aims to bridge pre-clinical and
postmortem findings by leveraging functional magnetic resonance imaging (fMRI) and an emotional pattern
separation task, which is designed to engage the anterior and posterior hippocampus. Our fMRI pilot data
suggest that unmedicated MDD (N=16) have diminished anterior-specific hippocampal activity during this pattern
separation task compared with HV (N=12). In the present study, we aim to examine anterior hippocampal
functioning and connectivity during this fMRI emotional pattern separation task in unmedicated patients with
MDD during a MDE (N=35), remitted MDD subjects (N=30), and HV (N=25). The remitted MDD group will include
currently unmedicated remitted MDD and remitted MDD patients on antidepressants to explore if fMRI activity
and connectivity changes of the anterior hippocampus are related to MDD remission or antidepressant effects.
These data have potential clinical significance because they could lead to the identification of a) a state or trait-
dependent biomarker of MDD and b) form the basis for targeted interventions.
The following K23 proposal presents a research and training program that will support the applicant on
the path to becoming an independent investigator and an expert in functional neuroimaging and the study of
hippocampal and hippocampal-dependent network dysfunction in MDD. The mentorship, formal coursework,
educational seminars, and hands-on experience in this training plan will facilitate development in areas of (1)
fMRI design, preprocessing, hippocampal-specific methods, and advanced analyses, (2) neuroscience of mood
disorders, neurobiology of the hippocampus, and hippocampal dysfunction in MDD, (3) the role of the
hippocampus in memory encoding and retrieval, (4) biostatistics (5) clinical research, RO1 grantsmanship &
professional development. The training and research plan proposed in the K-23 will give me the professional
and technical skills needed to launch my independent research career and become a future leader in the field.

Public health relevance
PROJECT NARRATIVE This grant employs task-based functional magnetic resonance imaging (fMRI) to examine whether anterior- specific hippocampal abnormalities documented in animal models of depression and postmortem studies are present in unmedicated patients with major depressive disorder (MDD) and remitted MDD. These findings could inform our understanding of the pathogenesis of MDD and the neurobiological impact of recovery and treatment. This proposal will also facilitate my development as an independent neuroimaging investigator, focused on studying hippocampal and hippocampal network dysfunction in mood disorders.